Testing and Development of Safe and Effective Medical Countermeasures for the Nation, Which Would be Used to Prevent and Treat the Medical Effects of Ionizing Radiation

This Interagency Agreement establishes a formal collaborative relationship between the NIAID, NIH and AFRRI, an element of USUHS, DoD, through which the Parties will collaborate on radiobiology research and development projects. NIAID’s primary focus remains in the areas of infectious diseases and biodefense research for the nation, although the NIAID Radiation and Nuclear Countermeasures Program (RNCP) is focused on diagnostics and treatments to address injuries resulting from a radiological or nuclear public health emergency. AFRRI’s primary interest is centered on health hazards associated with radiation exposure, with particular emphasis on the military population. It is acknowledged that medical products developed for the military may have direct applicability in civilian settings and vice versa. With a commitment of both organizations to develop effective medical countermeasures against radiation threats, a partnership has developed between the Parties to initiate synergistic research projects. Development of safe and effective approaches for radiation injuries remains a high priority in national preparedness, and research achievements in medical radiobiological research have applicability to general medical biodefense. For example, exposure to ionizing radiation results in the disruption of cellular immune functions, which leads to increased susceptibility to agents of bioterrorism, as well as infectious diseases. By using NIAID’s core competencies and expertise in supporting and managing pre-clinical and clinical infectious disease research and development programs, and AFRRI’s expertise, technology, research materials, and unique radiobiology research facilities, efficiencies and economies of effort will result. This Agreement sets forth the understanding of both Parties with respect to their rights and responsibilities in this collaborative effort.